NK cells, their receptors and cancer therapy

Recent high-profile advances have reinvigorated enthusiasm for immunologic and cell-based therapies for
cancer. While the first 15 years of this Program focused on related donor sourced products and defining the
immunogenetics of NK cell contributions to allotransplantation, the adoptive transfer of single donor products is
limited to specialty centers because of high cost, difficulty in exporting, and inability to test multi-dosing strategies.
We have formed new strategic partnerships to shift from single donor products to off-the-shelf approaches. This
approach is simpler for protein-based NK cell immune engagers, as they are readily druggable, but more
challenging for cell products. Therefore, our overall goal is to develop off-the-shelf NK cell products to be used
alone or in combination with novel immune engagers. We have assembled a team of Minnesota and international
experts to lead the Projects and Cores. In Project 1, we discovered that NKG2C+ adaptive NK cells induced by
CMV have properties of immune memory, exhibit a unique methylation signature similar to CD8+ T cells, and are
primed for anti-tumor activity. Our group also published the 1st clinical link between adaptive NK cells and
reduced rates of leukemia relapse in 2016. We will now conduct a multi-institutional phase I/II trial of allogeneic
KIR-HLA mismatched adaptive NK cell infusions to treat patients with AML/MDS. We will also perform preclinical
testing of off-the-shelf NK cell products and novel immune engagers called tri-specific killer engagers (TriKEs).
TriKEs contain 3 arms: an arm that engages the CD16 activating receptor on NK cells; an arm that specifically
engages a tumor antigen on cancer cells; and an IL-15 linker. In the current funding, we discovered that IL-15 is
superior to IL-2 in promoting in vivo NK persistence and expansion; however, it also stimulates host CD8+ T cells
in many subjects, and we will test whether IL-15’s targeted delivery via TriKE minimizes bystander T cell
activation. Project 2 will focus on NHL and clinically test a dual-targeted strategy using an off-the-shelf, iPSC-
derived NK (iNK) cell product containing a CAR against CD19, a CD16 receptor, and membrane bound IL-15.
Preclinically, we will test whether targeting NK cell metabolism can improve in vivo NK cell performance. Project
3 will extend off-the-shelf iNK cell therapies into a solid tumor setting. Initial testing of adaptive NK cells in ovarian
cancer showed that the intraperitoneal (
IP) space is immune privileged and allows for NK cell persistence. We
will conduct a phase I clinical trial to determine whether IP delivery of off-the-shelf iNK cells expressing a non-
cleavable CD16 (FT516)
improves outcomes among patients with ovarian cancer.
Preclinically, we will test novel
immune engagers (TriKEs) in combination with FT516 and a new iNK cell product expressing a chimeric
CD64/16A receptor capable of multi-antibody targeting. Projects will be supported by the Administration &
Clinical Research Support (Core A), Biostatistics (Core B), and Immune Monitoring & Tissue Analysis (Core C)
resources. This Program will build upon our success in establishing a signal of clinical efficacy with single-donor
NK cells by moving from individually sourced related donor products to multi-dosed, off-the-shelf strategies.

Public health relevance
Natural killer (NK) cells can recognize and kill cancer cells; however, their use in adoptive cancer therapy has been limited by several factors including limited supply of cells and host immune responses that interfere with NK cell survival and targeting of cancer cells. This Program will advance our understanding of basic immunology of human NK cells and develop off-the-shelf NK cell products that can optimally target specific types of cancer.